Nathan Shock Center of Excellence in Basic Biology of Aging

OVERALL PROJECT SUMMARY
This application is for renewal of the Nathan Shock Center of Excellence in the Basic Biology of Aging
at the University of Washington and affiliated institutions. This Center has over the past 25 years
provided key resources in support of investigators who study the biology of aging. This application
continues a theme that emphasizes outreach and service to the broadest community of investigators
in the gerosciences. Of proximal relevance is the characterization of aging-related phenotypes of
longevity and healthspan. As our Center services must be easily accessible to outside users, our
Longevity and Healthspan Core (Core E) focuses on invertebrate assays, many of them novel. Two
other Resources Cores focus on the high dimensional assessments that are closely related to aging
phenotypes: Protein Phenotypes of Aging (Core C) and Metabolite Phenotypes of Aging (Core D).
Sophisticated computational and bioinformatic tools for data analysis and optimal insight are provided
by the Artificial Intelligence and Bioinformatics Core F. Each of these four Resource Cores is led by
highly respected experts in that field, including Michael MacCoss and Judit Villen (Core C), Daniel
Promislow (Core D), Matt Kaeberlein and Maitreya Dunham (Core E) and Su-In Lee (Core F). Each
will push the envelope of appropriate technologies, developing new state-of-the art approaches for
assessments that are the most applicable to gerontology and making them accessible to the national
aging community. The Research Development Core (Core B) will continue to support pilot and junior
faculty studies, with a firm focus on outreach of service to the national geroscience constituency. The
Administrative and Program Enrichment Core (Core A) supports administrative management, an
external advisory panel, courses, and data sharing and dissemination. Core A’s program of seminars
and symposia will continue a focus on sponsorship and organization of national courses, meetings
and pre-meetings, as well as workshops in the fields allied to our Resource Core Services. In
coordination with other Nathan Shock Centers, we will support a new Geropathology Research
initiative.

Public health relevance
UW NATHAN SHOCK CENTER OVERALL - PROJECT NARRATIVE We apply for renewal of the Nathan Shock Center of Excellence in the Basic Biology of Aging at the University of Washington, which has for 25 years provided key resources supporting investigators who study the biology of aging. The overarching goal of this Center is to have a positive impact on the field by accelerating research discovery and providing research support for investigators nationally and internationally, particularly junior investigators in the process of building their own research programs. We will accomplish this goal through six cores that function synergistically together: four Resource Cores with particular expertise in protein (Core C) and metabolite (Core D) phenotypes of aging, invertebrate longevity and healthspan phenotypes (Core E) and artificial intelligence and bioinformatics (Core F), along with a Research Development Core (Core B) that supports external pilot projects and junior faculty studies, and an Administrative and Program Enrichment Core (Core A) that supports administrative management, an external advisory panel, sponsorship and organization of national meetings and pre-meetings, courses, workshops and seminars, and, in coordination with other Nathan Shock Centers, a Geropathology Research initiative.